Protein Phosphatase Action in Mammalian Spermatogenesis and Sperm Function

DESCRIPTION (provided by applicant): Four isoforms of protein phosphatase 1 (PP1α, PP1β, PP1γ 1, and PP1γ2), derived from three genes, are virtually identical, except at their extreme C-termini. The isoforms PP1γ1 and mammalian-specific PP1γ2 derive from splice-variant transcripts of a single gene (Ppp1cc). Although all four PP1 isoforms are expressed in testis, PP1γ2 is by far predominant in male germ cells, and is the sole PP1 isoform present in mammalian spermatozoa. The PP1γ2 isoform has a unique 22 amino acid C-terminal tail. Targeted deletion of Ppp1cc leads to sterility of -/- males due to grossly defective morphological development of spermatids and faulty spermiation. We tested whether transgenic expression of PP1γ2 or PP1γ1 driven by the testis- specific Pgk2 promoter or the Ppp1cc endogenous promoter could restore fertility of Ppp1cc -/- males (rescue mice). Our preliminary studies show that normal sperm morphogenesis and fertility are restored only when adequately high levels of PP1γ2 are expressed in differentiating male germ cells. This restoration of fertility occurs even when the PP1γ1 isoform is completely absent. Low levels of PP1γ2 result in poorly motile sperm with several morphological abnormalities. PP1γ1 rescue mice also produce greater sperm numbers than Ppp1cc -/- mice. However, sperm are grossly malformed and completely immotile. The focus of this proposal is to identify the absolute and isoform specific requirement for adequate levels of PP1γ2 leading to normal structure and function of mammalian spermatozoa. We will determine whether the isoform specific function of PP1γ2 is determined by its C-terminus. Finally, we will ascertain how limiting levels of PP1γ2 alter the sperm proteome, thus resulting in structural deformities and impaired sperm function. These studies will continue to unravel novel mechanisms involved in mammalian sperm morphogenesis and function, and thus lead to simple diagnostic tests for fertility in man and other mammals based on the level of PP1γ2 in spermatozoa. PUBLIC HEALTH RELEVANCE: Statement Alternatively spliced protein phosphatase PP1γ2 isoform of PP1 γ gene plays an essential role in spermatogenesis and mammalian reproduction. However, molecular mechanisms responsible for its regulation and action in testis and spermatozoa are unclear. We will identify how PP1γ gene and its protein product PP1γ2 in testis and spermatozoa are responsible for sperm formation and function.

Public health relevance
Statement Alternatively spliced protein phosphatase PP1γ2 isoform of PP1 γ gene plays an essential role in spermatogenesis and mammalian reproduction. However, molecular mechanisms responsible for its regulation and action in testis and spermatozoa are unclear. We will identify how PP1γ gene and its protein product PP1γ2 in testis and spermatozoa are responsible for sperm formation and function.